Institute for Population Research

Overall: Summary
The mission of the Institute for Population Research [IPR] is to promote population science at Ohio State
University. The defining goals of IPR are: (i) to promote the application of theory and models from multiple
disciplines to issues in population science, resulting in far richer and more informative conceptualizations in
population research; (ii) to support for junior scientists, both in developing necessary skills for innovative and
high-impact population research and in navigating professional advancement; (iii) to nurture collaborative
research that crosses disciplinary boundaries, particularly team science to address complex problems; and (iv)
to maximize investment of resources in new population science projects and, correspondingly, a slim and
efficient administrative structure. To achieve these goals, IPR carries out activities and services through two
research infrastructure cores, an Administrative Core and a Development Core. The Administrative Core
handles all routine administrative tasks required to successfully implement IPR's activities and services. The
Development Core is the heart of IPR, as judged by its contribution to achieving the goals specified above. In
addition to the large IPR Seed Grant Program, this core will continue to sponsor Grant-Writing Workshops, IPR
speaker series (weekly seminar, annual lecture) and affiliate travel to the annual meetings of the Population
Association of America. New this cycle, the Development Core will also support Generative Workshops as a
mechanism for launching/advancing collaborative research projects, Rapid Response Grants to meet short-
term needs preceding submission of applications, and workshops and one-on-one consulting in Transparent
and Reproducible Research in Team Science to address the increasing demands for new practices and tools.
As a relatively new population science center, IPR to date has been deliberate in investing resources in
activities and services with the highest potential for research payoff. IPR's largest single activity, the Seed
Grant Program, is an example where substantial investments in projects at an early stage have yielded
significant returns, both scientific and financial, for Ohio State and for the wider research community. The
activities and services described in this application are designed to nurture innovative research, assist at all
stages of the funding process (from proposal writing through submission and post-award management), and
provide the tools, environment, and incentives for collaboration and intellectual exchange. With the strong
foundation built during the current award period, and the momentum provided by the research productivity of
our affiliates and the launching of exciting and innovative projects, IPR is well-poised to promote the continued
growth of innovative and high-impact population science in an increasingly complex interdisciplinary
environment.

Public health relevance
Overall - Narrative The proposed infrastructure award will support services and activities designed to enhance population science research at Ohio State University. This research will lead to better understanding of the determinants of child and adult health, in both the U.S. and outside the U.S. It will also lead to better understanding of the determinants and consequences of changes in family life in the U.S. (marriage, childbearing), and the consequences of immigration to the U.S. Findings from the population science research supported by this award will inform interventions that aim to address prevalent child and adult health disparities, inform policies designed to allow individuals to achieve their aspirations for family life, and inform policies that make immigration maximally beneficial to all parties.